2023 Organellar Channels and Transporters GRC & GRS

Project Abstract/ Summary
This project aims to support the attendance of young faculty, under-represented minority scientists, graduate students, and
post-docs at the 2023 Gordon Research Conference (GRC) and associated student/postdoc-run Gordon Research
Seminar (GRS) on “Organellar Channels and Transporters”. These GRS and GRC will be held in Castelldefels, ES, on
August 5-6 and August 6-11, 2023, respectively.
These meetings will bring together scientists from many disciplines working on membrane transport proteins from a wide
variety of intracellular organelles in the animal, plant, fungal, and prokaryote systems. They aim to capture the most recent
discoveries in the field and the emerging technology and trends of integration among different organelles and processes,
as well as their relevance for the understanding and treatment of common and rare human diseases associated with the
dysfunction of organellar channels and transporters. The meeting will consist of platform sessions, short talks, poster
sessions, round tables, communal dining, and plenty of social time and conversations that will provide ample opportunity
for sharing the latest cutting-edge research results as well as technical and conceptual advances, for exploring collaborative
possibilities, and for identifying new ways to treat human diseases.
We request funds from NCATS to support junior invited speakers (assistant and associate Professors, and under
representative minorities) who have achieved breakthrough discoveries; to facilitate the attendance of graduate students,
postdoctoral fellows, and junior faculty, including but not limited to women and/or other minorities at the GRS and GRC,
and to foster productive scientific and career consulting discussions between senior and young scientists.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Organellar Channels and Transporters, held for the 4th time in 2023, is dedicated to ion channels and primary or secondary transporters from intracellular organelles in animals, plants, and yeasts. It aims to bring together students, postdocs, and early career to senior scientists working in fields from plant biology to human diseases to share new, unpublished work and identify new concepts and challenges in this rapidly expanding field.